Trajectories and Markers of Neurodegeneration in Carriers of the Fragile X Premutation

Project Summary/Abstract
“Will I get FXTAS?”, “How much time do I have?”, and “What can I do to stop it?” These are the
pressing questions, without clear answers, from carriers of Fragile X Messenger Ribonucleoprotein 1 (FMR1)
premutation alleles, trinucleotide repeat expansions that occur in about 1 in 110-250 females and 1 in 400-850
males worldwide (or at least 850,000 people in the U.S.). The premutation causes a toxic increase in FMR1
mRNA, which leads to a cascade of molecular, cellular and brain degenerative changes including abnormal
alternative splicing, altered miRNA biogenesis, mitochondrial dysfunction, calcium dysregulation, white matter
disease, and brain atrophy. These changes contribute to the development of fragile X-associated tremor ataxia
syndrome (FXTAS) which is characterized by tremor, gait ataxia, parkinsonism, executive dysfunction and
dementia, and eventual premature death. However, FXTAS has incomplete penetrance in FMR1 carriers, and
the size of the mutation alone has limited prognostic value, highlighting the importance of other factors
contributing to risk. Over the past 16 years, we have conducted a longitudinal study of male carriers at risk for
FXTAS and healthy controls to examine the prodrome of the disease and the mechanisms and key markers
associated with “phenoconversion” – which is when carriers begin to show the first clinically significant
neurological symptoms. We have been successful in identifying several preliminary brain imaging,
neuropsychological, motor and metabolomic/proteomic markers, but they have been determined using a
relatively small cohort of phenoconverters without the use of rigorous predictive modeling. The goals of this
phase of the project are to a) improve the precision of neurological assessment of preclinical and early FXTAS,
b) validate biomarkers able to identify carriers at highest risk of phenoconversion and track disease
progression and severity, c) establish brain imaging, motor and oculomotor, and neuropsychological prognostic
markers for FXTAS, and d) utilize modern machine learning techniques to discern an optimal combination of
markers to enhance prognostic sensitivity for FXTAS phenoconversion. To accomplish these aims, we will
continue longitudinal observations of 44 carriers without FXTAS and 27 controls already enrolled in the study,
and of 45 new carriers without FXTAS and 30 new controls that we will enroll during the proposed project. The
overarching goal of this project is to develop an approach to identify carriers at high risk for FXTAS who are
eligible for prophylactic therapeutics, and to obtain optimal measures for tracking treatment response in future
clinical trials.

Public health relevance
Narrative Men with the fragile X premutation are at high risk for developing a neurodegenerative disease called fragile X associated tremor ataxia syndrome (FXTAS) that commonly involves progressive problems with movement and cognition. This project follows male carriers over time using a variety of brain imaging, genetic, body metabolism, cognitive and neurological measures to identify early markers of risk before the disease manifests, and it carefully examines changes in these markers during the “conversion” process when the first clear symptoms arise. The information gained from this project will help to determine the factors that identify which carriers are most likely to develop FXTAS and it will provide critical measures that can be adopted for future clinical trials and interventions to prevent or slow the disease process.